District of Columbia Center for AIDS Research

OVERALL RESEARCH PLAN
PROJECT SUMMARY
This renewal application for the District of Columbia Center for AIDS Research (DC CFAR) presents the
scientific and public health achievements of the DC CFAR to date, describes our unique citywide, multi-
institutional model, underscores the strong leadership and administrative infrastructure upon which the CFAR
is built and articulates a vision for our future scientific directions.
The DC CFAR includes 227 HIV investigators from eight DC collaborating institutions – George Washington,
Georgetown, Howard and American Universities, the Veterans Affairs Medical Center, Children's National
Health System, DC Department of Health and Whitman-Walker Health. Our mission is to intensify our multi-
institutional effort to promote and support research that contributes to ending the HIV epidemic in Washington,
DC and beyond in partnership with government and community. Notable achievements from the previous
funding period provide a strong foundation for our future, including a 46% increase in our Funded Research
Base (FRB) from $11.6M in 2015 to $17.0M in 2018; over $2.8M in pilot awards granted since 2010; a 761%
return on investment on completed pilot awards funded from 2010-2016; and >1,100 Core services provided
and 667 HIV-related articles published by DC CFAR investigators from 2015-2019.
With substantial institutional support of $2.8M over five years, and numerous scientific and programmatic
innovations underway, the DC CFAR is well-positioned to respond to the critical challenges of our local
epidemic. The Specific Aims of the DC CFAR are to:
Aim 1: Provide scientific leadership and institutional infrastructure to advance HIV research among the
eight collaborating DC CFAR institutions;
Aim 2: Stimulate and support innovative and consequential HIV research in the basic, clinical,
prevention and social and behavioral sciences while promoting an interdisciplinary approach to
addressing the NIH high priority scientific HIV focus areas;
Aim 3: Drive the development and recruitment of early stage, new, and women and underrepresented
minority HIV investigators; and
Aim 4: Enhance communication and foster meaningful new collaborations between DC CFAR
investigators and academic, government, community and clinical partners.
To achieve these aims, the DC CFAR supports five Cores: Administrative to provide scientific leadership and
fiscal oversight; Developmental to oversee the pilot awards and mentoring programs; and Basic Sciences,
Clinical and Population Sciences, and Social and Behavioral Sciences to provide services to support
innovative and multi-disciplinary HIV research. Lastly, the DC CFAR supports two Scientific Working Groups –
HIV Cure and the Ending the HIV Epidemic – to galvanize research in these high priority areas.

Public health relevance
PROJECT NARRATIVE Overall The DC CFAR's mission is to intensify our multi-institutional effort to promote and support research that contributes to ending the HIV epidemic in Washington, DC and beyond in partnership with government and community. The CFAR achieves this mission by providing scientific and administrative leadership to advance HIV research among the eight collaborating DC CFAR institutions; stimulating and supporting innovative and consequential HIV research in the basic, clinical, prevention and social and behavioral sciences; driving the development and recruitment of early stage, new, and women and underrepresented minority HIV investigators; and enhancing communication and fostering meaningful new collaborations between DC CFAR investigators and academic, government, community and clinical partners.